Zooming into the fish's brain-What is really going on! Connectomics analysis of larval zebrafish.

Project 3
The principal goal of Project 3 is to better link the behaviors of zebrafish to underlying synaptic circuitry. In both the
central and peripheral nervous systems we will leverage recent advances in high throughput serial section electron
microscopy to acquire high resolution image data and then use new machine learning approaches to analyze this data. This
effort will use three kinds of approaches: 1) sparse manual reconstructions of particular pathways related to particular
behaviors, 2) dense reconstruction of synaptic connections to reveal all the input and output of neurons that is spatially
correlated to markers that show excitatory and inhibitory cell types and activity, and 3) saturated reconstructions that also
provide glial, vascular, sensory end organs and muscle (cardiac, skeletal and smooth).
The zebrafish is the only vertebrate animal where obtaining a saturated reconstruction of the entire nervous system is
conceivable. The connectomic data will be used initially to test the validity of published models of how a behavior is
instantiated in the nervous system. In the likely event that there is some difference between what was expected based on
published models and what is found, these data will be used to help formulate new models. Second, the data will be used
to reveal previously unknown pathways, such as those that interconnect the autonomic and somatic nervous systems.
Finally we will build the necessary infrastructure so the data can be used as a public, freely addressable atlas for any
researcher who has interest in tracking the long and short range neural pathways that underlie vertebrate behavior at the
resolution of single synapses.

Public health relevance
The research plan we propose aims at a comprehensive multi-level understanding of how the brain and the body interact to respond adaptively to a potentially harsh and unforgiving environment. Among the many internal factors that are under constant homeostatic regulation, we focus on the bi-directional dialogue between the brain and the heart, since the cardiovascular system and its role in regulating oxygen delivery is one of the most critical and universal control systems within the animal kingdom. A central aspect of our approach is the generation of a complete brain and body connectome of the larval zebrafish, a map which will be the first ever generated in a vertebrate, and which will be critical in both testing the validity of many extant models, and perhaps discovering new pathways within the interconnected neural circuits that serve the changing needs of the body during behavior.